Single dose azithromycin to prevent cholera in children

PROJECT SUMMARY
Vibrio cholerae causes 3 million cases of cholera and 100,000 deaths annually. Young children are most
vulnerable to cholera, yet they are not protected by current vaccines. More aggressive approaches are needed
to prevent the cholera, especially in young children. To meet this challenge, the World Health Organization has
targeted the elimination of the global threat of cholera transmission by the year 2030, but the strategic
approach to achieve this ambitious goal has not yet been determined.
For patients with cholera, effective antibiotic treatment dramatically reduces the severity of infection and
prevents the release of trillions of V. cholerae bacteria into the environment. However, while antibiotics are
often effectively used to prevent other infections, there are no standards for the use of antibiotics to prevent
cholera. As a result, there is tremendous variation in practice, and antibiotics with unproven efficacy are
frequently given to prevent cholera. These unproven approaches may needlessly contribute to antibiotic
resistance in both V. cholerae and important bystander bacteria as well. For this reason, the World Health
Organization Task Force on Cholera Control has recommended a halt to widespread antibiotic use for
preventing cholera, and instead recommends that studies be done to test the effectiveness of antibiotics for
cholera prevention as well as their impact of this on antimicrobial resistance.
Our proposal addresses this exact knowledge gap. We will determine whether single-dose azithromycin is
effective in preventing V. cholerae infection in children who live in a household where there has been a case of
cholera. Without intervention, these children have a 30% chance of developing infection within one week.
While a single-dose of azithromycin is a preferred treatment for cholera, azithromycin to prevent cholera has
never been studied. Azithromycin has been found to be beneficial in other mass prevention studies in children,
but the impact of single-dose of azithromycin on antibiotic resistance has not been sufficiently tested. We
anticipate that this study will result in the more effective and judicious use of antibiotics to prevent cholera in
children.

Public health relevance
PROJECT NARRATIVE We will determine whether single-dose azithromycin is effective in preventing cholera in children who are at extremely high risk of infection. We will also determine the effect of this intervention on the development of antibiotic resistant bacteria. The results will inform future strategies to prevent cholera in children, and improve our understanding of the impact of azithromycin on antibiotic resistance.